Targeting the stromal niche for tissue-resident lymphocytes in asthma

Project Summary/Abstract
The current paradigm of asthma attributes epithelial cells in recruiting immune cells that promote
pathologies seen in asthmatic airways, including infiltration of immune cells and mucous metaplasia. What is
less clear is how stromal cells surrounding the airway alter the inflammatory response to allergic challenge,
and whether targeting these cells represents a viable strategy for asthma therapeutics. This proposal aims to
characterize a targetable stromal factor that alters immune cell accumulation in the lung and define the
downstream effects of these immune cells on airway epithelial cells. Our preliminary data demonstrate that
fibroblast-specific deletion of Hhip promotes the accumulation of T cells with tissue residency features (tissue
resident lymphocytes, or TRLs) within the adventitial space surrounding the airways, suggesting that host
factors in the lung can alter the inflammatory response after allergen challenge. Utilizing a combination of novel
genetic tools to trace and delete Hhip+ fibroblasts, human organoid platform, and a novel pharmacologic
reagent made in our lab to target TRL accumulation, this proposal will determine the mechanism by which
stromal factors in the lung modifies TRL accumulation in response allergen challenge. Furthermore, we will
determine whether host factors that modify TRLs can be leveraged as pharmacologic therapy to attenuate the
inflammation and airway metaplasia seen in asthmatic airways. Finally, we will develop an ex vivo organoid
model of human asthmatic airways that preserves the stromal-epithelial-immune architecture for drug
screening. Successful completion of this proposal will highlight an unrecognized axis whereby a dysregulated
lung stromal niche can drive the maladaptive expansion of TRLs that promote mucous metaplasia in asthmatic
airways, and provide preclinical studies of novel therapeutic agents to target the stroma in asthma.

Public health relevance
Project Narrative Most drugs for asthmatics target immune cells in the lung that drive the allergic response, but it is not clear why these abnormal immune cells remain in the lung in the first place. This proposal will explore how fibroblasts, a structural cell in the lung, controls the inflammation caused by allergens. Furthermore, we will test new therapy targeting lung fibroblasts that could potentially treat the underlying conditions promoting allergic inflammation.